The role of insufficient sleep and depression on hippocampal-dependent memory trajectories across the adolescent transition

Project Summary
This K08 proposal will address a critical gap in our fundamental knowledge of the effects of insufficient sleep
and depression on longitudinal sleep-dependent memory development and will prepare this applicant,
Katharine Simon, PhD, to become an independent translational investigator with expertise in sleep, memory,
and psychopathology across development. Depression in adolescence is a growing public health concern, with
symptoms beginning during the transition to adolescence (9 -12 years)1 and conferring heightened risk for
long-term deleterious psychological and cognitive outcomes.20-21 In contrast to other clinical disorders,
depression is associated with specific deficits in hippocampal-dependent (HcDep) memory (e.g., declarative
memory).9-11 Although the brain mechanisms underlying depression-related memory deficits are not
understood, one potential risk factor may be insufficient sleep (e.g., short sleep duration, variable timing, or
poor quality) given the critical role of sleep in supporting new hippocampal-dependent memory formation
(sleep dependent memory [Hc-SDM]).12 The transition to adolescence is a particularly vulnerable time that
involves increasingly dramatic changes to sleep patterns.2,3 Although a few nights of insufficient sleep does not
consistently affect HcDep memory performance in adolescents18,50-53; typical insufficient weekly sleep is
associated with reduced hippocampal volume.19 At present, it is clear there is a fundamental gap in our
knowledge of the individual trajectories of insufficient sleep, depression, and Hc-SDM across the
adolescent transition and the longitudinal associations between these factors. To address this question,
27 pre-adolescents (9 to 12 years) will be assessed using a repeated measurement-burst design with sampling
at quarterly intervals over a year using a personalized, mobile health (mHealth) platform. At each quarterly
evaluation, for 7 consecutive days, participants will complete daily sleep diaries, ecological momentary
assessments, and Hc-SDM tasks. The hypothesize is that insufficient sleep and depression symptoms across
the adolescent transition will predict long-term Hc-SDM performance trajectory deficits. This Mentored Clinical
Scientist Research Career Development Award will support Dr. Simon’s training goals to acquire skills and
knowledge in 1) gaining expertise in naturalistic, longitudinal cognitive and clinical assessment using mHealth
and wearable devices, 2) training in clinical pediatric research, and 3) intensive repeated-measure analyses.
These training aims will build on Dr. Simon’s prior training in cognitive neuroscience and clinical psychology
and expertise in short-term experimental sleep-dependent memory research. Furthermore, the training Dr.
Simon will gain from this K08 is an essential step to become an independent developmental translational
researcher and will directly lead to my future R01 application to further evaluate the longitudinal trajectories of
insufficient sleep and depressive symptoms on older adolescents’ Hc-SDM memory and identify key windows
in which sleep-based interventions can support cognitive trajectories in depressed adolescents.

Public health relevance
Project Narrative Depression in adolescence is growing public health concern, with symptoms beginning as early as pre- adolescence, and conferring heightened risk for long-term deleterious psychological and cognitive outcomes. The purpose of this K08 proposal is to prepare this applicant for a career in translational pediatric research, by investigating the effects of insufficient sleep and depression on longitudinal sleep-dependent hippocampal memory trajectories across the adolescent transition in typical and depressed youth. The knowledge gained from this proposal will address a critical gap in our fundamental knowledge of the individual trajectories of and longitudinal associations between insufficient sleep, depression, and sleep-dependent hippocampal memory across the adolescent transition, and help to identify key timepoints for sleep-based interventions for mental health and cognition across this neurocognitive sensitive period.